Development of foundational collaborations and capabilities to advance exposome research in childhood-onset rheumatic diseases and other pediatric autoimmune conditions

PROJECT SUMMARY
The primary vision of this project has been the establishment of investigator and network collaborations that
will advance study of the role of the exposome in childhood-onset rheumatic diseases and other autoimmune
conditions, with an overarching goal of creating new research resources and forming new teams of pediatric
investigators from existing networks that can contribute to the nascent “EXposome in Autoimmune Disease
Collaborating Teams” (EXACT) network. We address this focus via collaboration between the EXACT-PLAN
consortium (initiated August 2023) and our two existing pediatric networks, which have pre-existing, extensive
phenotype and biobank resources: the investigator-sponsored Childhood Arthritis and Rheumatology Research
Alliance (CARRA), which sponsors the CARRA Registry, and the NIH/NCATS funded Genomic Information
Commons (GIC). Over the first two years of EXACT-PLAN, we have established collaborations that take the
initial steps to advance our understanding of the role of exposures in the development and course of
autoimmune diseases (AIDs), resulting in a shared definition of `Pillars of Exposome Studies in Autoimmunity'
to help drive further EXACT collaborations. At the same time, we have made substantial progress towards
fulfilling our aims for the parent project, which are two-fold: (1) Establish a collaborative framework between
investigators of the CARRA and GIC networks for augmenting current research activities with exposome data
and biobank specimens; and (2) pilot the linkage of publicly available exposome data sets, including air and
water quality databases, to existing data sets that the CARRA Registry and GIC maintain. We are further
developing and adapting policies, protocols, informed consents, case report forms, and patient surveys that are
specifically targeted to incorporate exposome data for childhood-onset rheumatic diseases and other
autoimmune conditions. For this supplement, we will further enhance collaborations between our two pediatric
networks (CARRA and GIC) with other EXACT-PLAN projects, focusing on the development of geographically
diverse pediatric cohorts for exposome-wide association studies, including for both disease-affected and as yet
unaffected children and adolescents. To facilitate collaborations with our EXACT-PLAN colleague projects, we
follow a near-term, shared vision of creating capabilities to conduct large-scale, exposure-wide association
studies and a longer-term focus on achieving the four pillars of exposome studies in autoimmunity that were
defined in the initial phase of EXACT-PLAN.
For this supplement, as we further collaborate within NIH's planned “EXposome in Autoimmune Disease
Collaborating Teams” (EXACT) network, we simultaneously pilot enhanced, longitudinal geographic histories
and exposome-ready cohort definition capabilities for the GIC research population at Boston Children's
Hospital (BCH). The GIC network is a cooperative, phenotype-genotype biobanking effort with 8 participating
pediatric academic medical centers across the US, with broad representation of subjects with differing
conditions (14 million subjects, ~24,000 with genome-linked phenotypic data, 180,000 biospecimens collected)
and provides search across sites to identify cohorts of individuals with and without rheumatic or autoimmune
diseases, with infrastructure also supporting subject recruitment and biobanking for future studies. At BCH,
GIC enrolls 2.9 million subjects of which ~7,000 have genome-linked phenotypic data, with ~60,000
biospecimens collected. To enable longitudinal geospatial analyses, we will use the supplement period to
explore local administrative linkages for geocoding as well as pilot BCH subject surveys, in a manner that will
be readily extensible to other GIC sites outside of BCH.
During this project period, we also plan to further engage with other EXACT-PLAN awardees in various
capacities, specifically: (1) Continue to collaborate closely on EXACT-PLAN geospatial analyses (John Pearce,
PI, Medical University of South Carolina) and establish new collaborations led by this group with the NIH-
funded “Network for Exposomics in the United States” (NEXUS; U24ES036819); (2) Identify unaffected
pediatric cohorts at the BCH GIC for collaborations with EXACT-PLAN colleagues studying the effect of
exposures in pre-clinical rheumatic disease populations (systemic lupus erythematosus, rheumatoid arthritis;
Jill Norris, PI, Colorado School of Public Health); (3) Identify and assist with recruitment of BCH GIC and
CARRA subjects with Juvenile Idiopathic Arthritis for a remote `ImmuneTracker' mobile app pilot (Wilson Liao,
PI, University of California, San Francisco); and (4) Identify pediatric AID cohorts at BCH GIC pertaining to
T1DM and celiac disease (Brigitte Norris, PI, University of Colorado).
Our multi-disciplinary project team includes researchers in pediatric rheumatology and the exposome,
technology experts, and patient representatives. Completion of the aims of this project will further enable new,
team-based collaborations to conduct future high-quality, best-practices exposome research for many pediatric
autoimmune diseases as part of the future EXACT network.

Public health relevance
PROJECT NARRATIVE Understanding the role of environmental exposures – the “exposome” – in the development of and response to treatment for childhood-onset rheumatic diseases and other conditions is an important area of research that remains understudied. This project supplement enables continuation and enhancement of collaborations between the two networks of pediatric researchers in our existing EXACT-PLAN project – the Childhood Arthritis and Rheumatism Research Alliance (CARRA) and NIH-funded Genomic Information Commons (GIC) – with other EXACT-PLAN projects, focusing on the development of geographically diverse pediatric cohorts for exposome-wide association studies, including for both disease affected and as yet unaffected children and adolescents. For this supplement, as we further collaborate within NIH's planned “EXposome in Autoimmune Disease Collaborating Teams” (EXACT) network, we simultaneously pilot enhanced, longitudinal geographic histories and exposome-ready cohort definition capabilities for the GIC research population at Boston Children's Hospital.